2017 Cancer Nanotechnology Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract The 2017 Cancer Nanotechnology Gordon Research Conference (CN-GRC) provides a unique and highly acclaimed forum where scientists at every stage of their career can share unpublished, innovative cancer research made possible by the use of nanotechnology. Held biennially since 2011, the conference was nearly oversubscribed in 2015 (GRC spirit calls for a limit of 200 attendees). To accommodate the demand, especially from the emerging generation of scientists, Gordon Research Seminar (CN-GRS) will be carried out in conjunction with the GRC for the first time. The conference will bring together a lively group of exceptional scientists to peaceful and scenic Mount Snow, VT in order to: 1) share cutting-edge research in cancer nanotechnology by experts representing the whole spectrum of life sciences; 2) foster discussion, exchange of ideas, and promote collaborations and 3) enhance the training and development of young scientists and promote diversity. A high priority of the CN-GRC and CN- GRS is to increase the diversity of participants. Towards this goal, funds are requested for travel and registration support of female and under-represented speakers.

Public health relevance
Project Narrative The goal of Gordon Research Conference & Seminar on Cancer Nanotechnology is to provide a platform for internationally renowned and early career scientists to discuss recent breakthroughs in the use of nanotechnology for the diagnosis and treatment of cancer. This forum will focus on new aspects of cancer biology, immunology, imaging, and therapy and showcase the work of a diverse group of experts from across the spectrum of life sciences. Furthermore, the addition of the Cancer Nanotechnology Gordon Research Seminar (CN-GRS) will help in the development of young cancer nanotechnology investigators and highlight their contribution to the field.